National Early Hearing Detection and Intervention (EHDI) Conference

Abstract
In March 1993 a National Institutes of Health Consensus Development Conference recommended that all
newborns be screened for permanent hearing loss before being discharged from the birth hospital. Since that
time, universal newborn hearing screening programs have been implemented throughout the United States with
all 59 states and jurisdictions now receiving federal funding to assist with the operation and improvement of an
Early Hearing Detection and Intervention (EHDI) program. The goal of these EHDI programs is to ensure that
all newborns are screened for permanent hearing loss before one month of age, those not passing the screen
receive a diagnostic audiological evaluation before three months of age, and those identified with permanent
hearing loss are referred to an early intervention program before six months of age. These benchmarks are
important because undetected hearing loss leads to significant delays in language, social and emotional
development, and academic achievement for children. An important contributor to helping EHDI programs
meet the EHDI benchmarks has been the annual National EHDI Conference, which has been held since 2001
and is now attended by more than 1,000 people each year. For almost 40 years, the National Center for Hearing
Assessment and Management (NCHAM) at Utah State University has assisted EHDI stakeholders in expanding
and improving EHDI programs, including the organization and management of the National EHDI Conference.
The EHDI Act of 2022 (PL 117-241) reauthorized funding for EHDI programs through FY2027 and is
administered by the U.S. Department of Health and Human Services. The law directs the Health Resources and
Services Administration (HRSA), the Centers for Disease Control and Prevention (CDC), and the National
Institutes of Health (NIH) to continue coordinating and advancing “a national program for the early
identification and diagnosis of [deaf or hard of hearing (DHH)] newborns and infants”. The National EHDI
Conference provides information, tools, and collaboration opportunities for those implementing the law,
including state and federal EHDI program staff, researchers, providers of services, students, families, advocates,
and others who help improve outcomes for children who are DHH. The National EHDI Conference seeks to
address these matters through poster and podium presentations, plenary sessions, instructional sessions,
networking, ancillary meetings, and other innovative methods while making the conference fully accessible for
the attendees who are DHH by providing American Sign Language interpreting and real-time captioning
services for all plenary, podium, and instructional sessions.

Public health relevance
Project Narrative As with the previous 24 conferences, the goal of the annual National EHDI Conference is to enhance the implementation of comprehensive state-based Early Hearing Detection and Intervention (EHDI) programs. The National EHDI Conference brings together a wide variety of attendees who learn from each other to improve services and outcomes for children who are Deaf or Hard of Hearing and their families. Funding for this project will support accessibility (using American Sign Language interpreting and real time captioning services) to facilitate communication, networking, and learning opportunities for attendees to move EHDI programs forward so that benchmarks are met and children who are Deaf or Hard of Hearing reach their fullest potential.